IGF::OT::IGF SUPPORT FOR EPIDEMIOLOGICAL STUDIES OF CANCER AMONG ATOMIC BOMB SURVIVORS

The purpose of this contract is to conduct epidemiological and multi-disciplinary studies of cancer among atomicbomb survivors.